PHASE II TRIAL--SAFETY/EFFICACY OF DEHSPM TREATMENT OF AIDS RELATED DIARRHEA

The purpose of this study is to determine the safety and efficacy of DEHSPM when given by injection to patients with documented Aquired Immune Deficiency Syndrome and refractory diarrhea.